Multi-modal dynamic risk prediction of thrombosis and bleeding in patients with cancer

Venous thromboembolism (VTE) is the second-leading cause of non-cancer death in ambulatory cancer
patients receiving chemotherapy. Despite evidence supporting the prescription of low dose direct oral
anticoagulants (DOACs) in ambulatory patients with cancer who are high-risk for VTE and low-risk for
bleeding, its implementation is almost nonexistent due to the absence of accurate hemostatic risk prediction.
The central hypothesis is that we can leverage population science and data science methodologies while
guided by clinical and ethical principles to ascertain and predict thrombotic and hemorrhagic outcomes in
~330,000 patients with cancer from three different healthcare systems in the US. These sites are selected for
their significant differences in age, sex, race, ethnicity, and cancer type to ensure fairness in model
development and application. Our two specific aims are: 1) To ascertain and validate incident VTE and CRB
outcomes from clinical notes in patients with cancer across three healthcare institutions; and 2) To develop,
externally validate, and deploy a multimodal, dynamic risk prediction model for incident VTE and CRB following
the initiation of anticancer systemic therapy to individualize preventive recommendations. We will pursue these
aims using several innovative methods including natural language processing (NLP) algorithms fine-tuned from
pre-trained masked language models, retrieval augmented generation (RAG) in large language model (LLM),
federated learning (FL) framework to allow for decentralized privacy-preserving data sharing, and multimodal
dynamic risk prediction with longitudinal trajectories from both structured and unstructured data. The proposed
research is significant because accurate thrombo-hemorrhagic risk prediction will lead to increased adoption of
risk-adaptive thromboprophylaxis to reduce complications in patients undergoing anticancer therapy. The
expected outcome of this proposal is the creation of validated VTE and CRB dynamic risk prediction models in
patients with cancer starting systemic therapy that are applicable for all racial and ethnic groups. The success
of our proposal will empower other clinical investigators to validate our work against their own datasets,
integrate it into clinical care, or join our ongoing FL network to further improve accuracy and applicability of the
multimodal individualized treatment effects model for thrombosis and bleeding.

Public health relevance
The proposed research is relevant to public health as the open-source machine-learning models for thrombosis and bleeding prediction available on completion of our project will be highly accurate and broadly representative of the US population. Its successful validation and use may also lead to reduced morbidity and mortality associated with cancer associated thrombosis. This proposal is also relevant to the part of NIH’s mission that pertains to utilizing innovation research strategies to enhance health, lengthen life, and reduce illness and disability in patients with cancer.